A comprehensive whole genome sequence scan for positive selection in southern Africa

PROJECT SUMMARY
An African origin for modern humans and the vast genetic diversity in the region is irrefutable. Within
Africa, southern Africa is home to the some of the oldest and most diverse extant human populations world-wide.
These populations, the KhoeSan, reside predominantly in the north-western parts of South Africa and throughout
Namibia and Botswana. In previous work (PMID 27474727), I and two of my mentors showed that fine-scale
genetic population structure between these KhoeSan populations reflects ecogeographical boundaries. In
addition to this unique KhoeSan ancestry, populations in southern Africa have been shaped by numerous
migrations from within Africa (e.g. Bantu-speaking peoples) and outside Africa (notably European and Asian
populations). Thus, the patterns of diversity observed in this area is unique with no comparable regions
elsewhere in the world. These southern African populations went on to further adapt to their new environment
which was plagued by disease, resource limitations and harsh climates. The role of positive selection in this
adaption, remains unknown.
Using one of the largest whole genome sequencing dataset collections encompassing numerous
southern African populations, we aim to: 1) scan these datasets for signals of positive selection and 2) evaluate
the functional, biological and potentially translational implications of these signals. This project will be the largest
and most comprehensive single study of natural selection on the African continent. The methods developed in
this study will inform future scans for natural selection in heterogenous, admixed African populations.
Furthermore, the findings will provide insights into how adaptation to the environment has shaped human
genomes and in turn, various phenotypes in this unique part of Africa - these results could be informative to all
populations with African ancestry.

Public health relevance
PROJECT NARRATIVE The influence of positive natural selection in shaping the genomes of southern African populations is largely unknown. In this study, using the most appropriate and accurate statistical method, we will scan large-scale whole genome sequencing datasets (> 1000 individuals from ~5 populations) for signals of positive natural selection and characterize the functional importance of identified signals. Ultimately, we aim to detect novel positive selection signals that could have a potential impact on various human phenotypes in a largely understudied population.